Decoding Gene-Environment Interactions in Complex Traits via Multi-Omics Approaches

PROJECT SUMMARY
Complex traits are influenced by the interplay of genetic variations, environmental exposures, and their
complex interactions. As environmental conditions shift, genetic variations that were once advantageous may
now contribute to diseases. Identifying the genetic basis for phenotypic differences and environmental adaptation
is particularly challenging due to the highly polygenic nature of these traits, extensive pleiotropy of the genes
involved, and the complexity of gene-environment interactions. The primary research focus of my lab is to unravel
the genetic basis of complex trait variation and novel trait evolution through two complementary tactics: (1) We
explore cryptic genetic variations that are unmasked by introducing environmental or genetic perturbations in
model organisms. (2) We investigate genomic signatures in natural populations that have adapted to extreme
environments. To accomplish our research objectives, we employ a combination of experimental and
computational methods, including cutting-edge comparative, quantitative, and evolutionary omics studies in both
natural and laboratory organisms. Over the next five years, our goal is to dissect a series of complex traits and
their interactions with dietary environments by linking the phenome with the genome, and via integrating
intermediate molecular phenotypes to construct a gene-transcript-metabolite-phenotype network. We aim to
uncover cryptic genetic variations that have been "hidden" under normal conditions but are revealed through
environmental perturbations using both inbred and outbred Drosophila populations, including a novel genetic
mapping resource. We will leverage multi-omic analysis to investigate how these variations influence the
phenotype of complex traits. Our research strategy includes three key lines: first, we will employ a powerful
mapping strategy to uncover cryptic genetic variations under environmental stress and gene-environment
interactions across different extreme dietary conditions; next, we will explore the phenotypic changes in
Drosophila populations induced by the environmental stress, which allows us to evaluate phenotypic variation
and heritability, and identify correlations among metabolic, developmental, and mitochondrial traits, the genetic
correlations of these traits and pleiotropy of associated genes; lastly, we will adopt a systems biology approach
to integrate genetic variations with transcriptomic and metabolomic data to uncover the relationships between
genetic variation, gene expression, metabolite profiles, and complex organismal traits. Overall, the successful
execution of this research is expected to uncover novel gene-environment interactions, cryptic genetic variation,
unknown pleiotropy, and elusive components of genetic architecture, significantly advancing our understanding
of complex traits. By pioneering new multi-omic strategies and providing a comprehensive framework for
dissecting the intricate networks linking genetic variation with phenotypic outcomes, this research holds
transformative potential for advancing precision medicine and offering new insights into complex diseases.

Public health relevance
PROJECT NARRATIVE This research will use Drosophila as a model system to uncover cryptic genetic variation and gene-environment interactions that influence metabolic, developmental, and mitochondrial traits in response to extreme dietary conditions. By integrating genetic, transcriptomic, and metabolomic data, we expect to identify novel genetic variants and regulatory networks that contribute to complex trait variation. These findings will enhance our understanding of complex trait architecture and how diet influences health, potentially informing new strategies for managing complex metabolic diseases in humans.